Head Start REDI Classroom and Home Visiting Programs: Long-Term Follow-up

PROJECT SUMMARY/ABSTRACT
A major goal of publicly funded early childhood education (ECE) programs for low-income families is to
address underlying social disparities in order to improve children's long-term educational attainment and health
outcomes. Rates of participation in ECE programs and public investment in these programs have grown
dramatically over the last 30 years, changing the context for understanding the potential long-term program
benefits. Whereas existing long-term studies (Perry Preschool, Abecedarian) compared the benefits of ECE
versus home care, the critical question facing ECE programs today is whether improvements in the quality of
contemporary ECE programming can have incremental long-term benefits. In order to optimize return on
investment, long-term studies evaluating costs and benefits of ECE program enhancements are needed. The
proposed study will examine the long-term outcomes and identify the public service and financial costs affected
by the two REDI interventions, enhancements to the Head Start classroom and home visit programming
respectively, and estimate their likely return on investment. We propose interviews with and administrative data
collection for participants in each of two ongoing longitudinal studies, the REDI-Classroom (REDI-C) trial
(n=356, retention=80%) and the REDI-Parent (REDI-P) trial (n=200, retention=86%), that have followed
children with detailed measurement of adaptive social-emotional and academic functioning from preschool into
adolescence. There are three aims: 1) Assess the long-term impact of REDI programs with follow-up
assessments that extend to early adulthood (age 23) for participants in the classroom program and through
high school completion (age 19) for participants in the parent program; 2) Collect new services and
administrative data from education, criminal justice, healthcare, and social service records to estimate the
costs linked to program effects and determine the long-term return on investment for the REDI-C and REDI-P
programs; and 3) explore the associations between initial REDI-C and REDI-P impacts on social-emotional/
self-regulation skills and later, long-term benefits, and explore possible moderation of intervention effects by
the quality of the school contexts experienced by participants in order to illuminate likely mechanisms of action
and inform future ECE intervention design.

Public health relevance
PROJECT NARRATIVE This project will follow participants from two randomized trials to evaluate the impact of the REDI-Classroom and REDI-Parent Head Start enrichment programs on the late adolescent and early adult outcomes of children who attended Head Start. Benefits in areas of educational attainment, employment, health, and reduced risky behavior (antisocial behavior, substance abuse, and risky sexual behavior) will be evaluated with self-reports, parent reports, teacher reports, and administrative data review. The project will contribute to public health by evaluating the long-term impact and mechanisms of action of preschool enhancements that aim to improve the educational attainment, productivity, and health of children growing up in low-income families.